Interrogating Complex Methylome Network with Integrated Chemical Biology Tools

Project Summary/Abstract: Epigenetic biology associates with inherited cellular cues to define
diverse cell fates with the same genome. Among essential epigenetic events is protein methylation
deposited by more than 60 human protein methyltransferases (PMTs) and recognized by hundreds
of effectors to render downstream functions. Because many methylation events are invisible in
cellular contexts for conventional methods, our understanding of epigenetic roles of protein
methylation is very limited. In the past five years, our laboratory has focused on developing novel
chemical biology technologies and implementing them to annotate novel methylation events and
their downstream outcomes. We plan to continue this research theme for technological, functional,
and conceptual advances. Regarding the technological advance, we envision developing a
collection of complementary chemical biology tools to annotate each PMT-target-effector axis in
the context of the complex methylome. For potential functional and conceptual advances as
supported by our preliminary data, we will characterize nonhistone and noncanonical histone
methylation events associated with transcriptional regulation and protein homeostasis. The
completion of this proposal is expected to reveal the molecular mechanisms of multiple protein
methylation events in their biologically relevant contexts.

Public health relevance
Project Narrative: This proposal is expected to develop a collection of chemical biology tools to interrogate biological functions of protein methylation events with disease relevance. The revealed mechanisms can elicit disease-associated biology and lead to novel therapeutic strategies.